Fabrication Research Core

PS-OC participants will have access to an extensive array of shared facilities to address the nanobiotechnology and nanofabrication needs of the Center. As the lead institution, Cornell will coordinate much of this core support. The array of capabilities for nanotechnology fabrication, characterization and development and biological imaging on the Cornell campus is unparalleled. Duffield Hall advances research by bringing together nanotechnology related projects in one building near the center of the Ithaca campus, specifically designed to encourage an interactive working environment. The PS-OC administration will be located in Duffield Hall, an ideal location from which to interact with established research centers. We will build on the successes of the Nanobiotechnology Center, which is also housed in Duffield, and through a close partnership with the NBTC, make extensive use of that organization's facilities infrastructure.

Public health relevance
This PS-OC brings together expert teams from the fields of physics, nano and microfabrication, engineering and cancer biology to develop novel trans-disciplinary approaches to better understand the complexity of cancer metastasis, the aspect of cancer that directly leads to patient morbidity and mortality. Approaches developed by physical scientists will be focused on the study of cancer. Our studies aim to identify novel mechanisms used by cancer ceils, but not normal cells, for growth and metastasis to distant body sites. These new mechanism provide povel drug targets, that aim towards arresting cancer metastasis.